Network for Emergency Care Clinical Trials: Strategies to Innovate EmeRgENcy Care Clinical Trials Network (SIREN) - Network Clinical Center (Hub)

Project Summary and Abstract
This supplement requests support of key activities and effort for key individuals that will allow the University of
Minnesota SIREN Hub to continue operations for recruiting participants into emergency care research.
Supplemental support is requested to maintain operations between the end of regular funding for the first 5
years of SIREN and start of the second 5 years of SIREN. Uninterrupted support of the Minnesota Hub will
ensure successful enrollment of participants into the ongoing SIREN trials (ICECAP, BOOST-3, and HOBIT),
and the continued support for the ancillary studies for these trials (Bio-BOOST to start soon, and Bio- HOBIT).
During the height of the COVID pandemic, SIREN research activities were paused or severely limited at our
Hub institutions and Spokes, and enrollment options (and accompanying funds to support research teams)
were often unavailable, despite continued Hub financial needs. We therefore anticipate ending the current
SIREN funding cycle with a deficit, which we will cover with funding from the Dean’s office and some
departmental funds. These internal funds are very limited, however, and are not available to cover the cost of
the continuation of our work until the next SIREN funding cycle. Thus, the supplement funds being requested
will be essential for uninterrupted Minnesota Hub performance.

Public health relevance
Project Narrative The unexpected nature of emergency conditions requires special preparation and skill to recruit and protect participants in emergency and critical care clinical trials. Yet, current treatments for many emergency conditions are unsatisfactory or unproven; well conducted, large clinical trials are sorely needed to advance emergency medical science and improve emergency and critical patient care. Many potential emergency research subjects are too ill or injured to engage in a meaningful research consent discussion, and emergency care is provided across a broad spectrum of settings, including ambulances, emergency departments, and intensive care units. Our experienced research team will implement pragmatic and successful strategies to accomplish enrollment under all these conditions and in all these settings at multiple midwestern locations as part of the Strategies to Innovate Emergency Care Clinical Trials Network (SIREN) national emergency care research network.